ABNORMALITIES OF GONADAL/PUBERTAL DEVELOPMENT USING LHRH ANALOG

Evaluation of the efficacy and dosage of the treatment of precocious puberty with leuprolide acetate. Plasma and urinary hormone levels are monitored to assess treatment effectiveness.